Human Plasma Cell Maturation & Maintenance through CD138, TNFRSF, and Modulation of Ig Secretion

Abstract:
Human long-lived plasma cells (LLPC) reside in the bone marrow (BM) and are responsible for the long-term
maintenance of serum antibody levels. The BM microniche provides important factors to fundamentally
transform early-minted antibody secreting cells (ASC) into LLPC for which CD138 and BCMA - a member of
the TNF receptor superfamily (TNFRSF) - play an important role. In this application, we explore old and new
CD138 binding factors in the BM microniche and long-established and newly discovered TNFRSF members in
the development of LLPC, as well as understanding how modulating the high energy function of antibody
secretion determines LLPC survival. If successful, this application will provide the basic mechanisms important
for durable vaccine design.

Public health relevance
Narrative: Human long-lived plasma cells (LLPC) reside in the bone marrow (BM) and are responsible for the long-term maintenance of serum antibody levels after vaccination. This application will understand the molecular mechanisms responsible for the generation and survival of LLPC in order to understand how to generate life- long protective immunity which has tremendous importance in vaccine biology.